PRODUCING USHER III RETINAL ORGANOIDS FROM PATIENT CELLS TO MEASURE THE EFFECT OF DRUG CANDIDATE

The Contractor shall provide project management for its own core team to ensure planning, execution, delivery of reports, and accurate and timely communication with the Contracting Officer’s Representative (COR), Contracting Officer (CO), and other stakeholders.

The Contractor shall manage appropriate teleconference meetings to keep the COR and the project team apprised of project progress. It is expected that during each task initiation and study protocol development, communication will be more frequent. The Contractor shall communicate via e-mail when teleconferences are cancelled as agreed upon by the Government. The Contractor shall also manage ad hoc meetings as requested by COR, which shall be scheduled by the Contractor within 48 hours of request. The Contractor shall be responsible for setting up the meeting with technology that enables screen sharing (ex. MS Teams, etc.), including a call-in number and passcode for the relevant participants and be responsible for moderating and participating in the meeting.

The Contractor shall submit Pre-Meeting Status Updates/Agendas, and Post-Meeting Minutes, as described in Paragraphs E and F below. The Contractor shall provide any Standard Operating Procedures, protocols, and methods upon request as outlined in Paragraph F below. Status updates and progress of experiments including new preliminary data generated between meetings will be reviewed and discussed at each teleconference meeting.